The Structural Dynamics of Translation and Translational Control

PROJECT SUMMARY
Translation of messenger RNAs (mRNAs) into proteins by the ribosome and the rest of the translation
machinery (TM) is a fundamental step in gene expression that is central to life. It is perhaps not surprising,
then, that the bacterial TM is a proven target for the development of new antibiotics and that many human
diseases have been causally linked to dysregulation of the human TM. Consequently, the mechanisms of
translation and translational control in bacteria and eukaryotes remain under intense investigation. Over the
past two decades, structural studies have revealed the large-scale structural rearrangements the TM
undergoes during protein synthesis. Unfortunately, the size, complexity, and conformational flexibility of the TM
have greatly impeded studies of these dynamics, significantly limiting our understanding of how they contribute
to the mechanisms of translation and translational control. Nonetheless, using a combination of single-
molecule fluorescence and structural techniques, we and others have characterized the dynamics of the core
steps of translation by the bacterial TM. Despite these accomplishments, critical gaps in our understanding
remain, particularly with regard to whether and how the dynamics of these core steps are modulated as part of
mechanisms of many biomedically important translational control strategies. To fill these gaps, we will use a
combination of single-molecule fluorescence, structural, and biochemical approaches to investigate how the
dynamics of the TM are steered to execute several fundamental translational control strategies that act during
initiation and elongation stages of translation in bacteria. In the case of translation initiation, we will investigate
how essential protein initiation factors (IFs) modulate the conformational dynamics of the ribosomal small
subunit and use conformational switching strategies to ensure the fidelity with which a ribosomal complex
correctly assembles at the start codon of the mRNA to be translated. In the case of translation elongation, we
will focus on ribosomal frameshifting and ribosome rescue. Ribosomal frameshifting, whereby the TM slips
backward or forward by one or more nucleotides on the mRNA, may be utilized at specific mRNA locations to
correct mutations that would otherwise result in production of an aberrant protein or to drive the synthesis of
multiple proteins from a single mRNA. Specialized TM components have evolved to induce frameshifting at
these specific locations, and our proposed studies of these features promise to reveal the still-elusive
mechanisms that underlie frameshifting. Using analogous approaches, we will also investigate how ribosome
rescue factors modulate the dynamics of the TM as part of the mechanisms through which they recognize and
rescue translationally compromised ribosomes. These studies will provide structure-based mechanistic models
of ribosome rescue systems that can inform the development of next generation small-molecule antibiotics.
Using a yeast in vitro translation system we have recently developed, we will expand these studies to include
eukaryotic-specific aspects of related translational control strategies in eukaryotes.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT (PROJECT NARRATIVE) The essential task of synthesizing all the proteins encoded in an organism’s DNA is executed solely by the ribosome and its associated translation machinery (TM). Using a powerful combination of fluorophore-labeled biological components and experimental approaches unique to the applicant’s and their collaborators’ laboratories, this proposal aims to elucidate aspects of the process through which the TM executes and controls protein synthesis that have thus far remained difficult or impossible to investigate. Because the bacterial TM is the target of many clinically relevant small-molecule antibiotics and dysregulation of the human TM plays a causal role in several human diseases, including numerous viral infections and cancers, the results of these studies are expected to identify new targets and strategies for the development of next-generation antibiotics and small- molecule therapeutics for treating viral infections, cancers, and other human diseases.